Robust ultra-high sensitivity proteomic technologies for limited samples

PROJECT SUMMARY
The majority of highly diverse biological processes are enabled through proteins, protein post-translational
modifications (e.g., glycosylation), proteoforms, protein interactions, as well as other biological molecules (e.g.,
lipids, RNAs, etc.). Aberrations of abundance, activity, function, integrity, and localization of these biological
molecules and their diverse interactions can lead to severe diseases. Furthermore, disruption of molecular
profiles and structural characteristics by novel targeted therapies can be an important biomarker for the
response to these drugs in personalized medicine approaches. Clinical and biological specimens are often
available in limited amounts, which greatly hampers the progress in diagnostics, therapy development, and
biomedical research. Microbiopsy and liquid biopsies may contain small populations of rare cells,
macromolecular complexes, or other biomolecular structures and species. Traditional analytical techniques
cannot be readily used for the analysis of small cell populations, microscopic clinical samples, and individual
cells, mainly due to limitations in sensitivity. Therefore, many biological and clinically relevant studies have not
been undertaken because of the lack of technology for such low-level samples. Here, we propose to develop
analytical platforms that will enable high sensitivity spatial multiomic analysis of scarce biomedical
samples. This task will demand the development of novel approaches in sample preparation, ultra-low
flow liquid phase separations interfaced with MS, MS data acquisition, and data analysis. Developing
such novel methods for thorough profiling of microscale samples and integrating them in innovative, robust,
and reproducible automated platforms capable of efficient and high sensitivity quantitative and structural
characterization of released glycans, peptides, intact proteoforms, protein complexes, and PTMs by MS will be
highly desirable for gaining biological insights into molecular mechanisms of the disease and discovery of
therapeutic targets and biomarkers for diagnostic and prognostic purposes. The developed platforms will be
evaluated using well-controlled model systems and applied in the most clinically relevant settings to examine
model line-based systems and primary samples.

Public health relevance
PUBLIC HEALTH RELEVANCE The proposed research will be focused on technology development for ultra-high sensitivity deep proteomic, glycomic, and spatial multiomic analysis of limited biological and clinical samples. Comprehensive molecular characterization of such samples at the level of digested proteins, released glycans, intact proteoforms, native non-covalent protein complexes, and protein interactions is presently an insurmountable challenge in bioanalytical research. The proposed technology offers an unprecedented opportunity for expanding our knowledge of molecular mechanisms of disease processes and identifying new paths toward the discovery of diagnostic and prognostic biomarkers using minuscule sample amounts. OMB No. 0925-0001/0002 (Rev. 08/12 Approved Through 8/31/2015) Page Continuation Format Page